GENETICS AND NONGENETIC FACTORS IN ALZHEIMER'S DISEASE

Pedigrees were constructed from family histories of patients participating in a dementia program to examine the genetic basis of Alzheimer's disease. Experimental protocols were developed for comparing phenotypes and genotypes of individuals with duplications of parts of chromosome 21, to identify genes contributing to mental retardation and dementia. Buffy coats from blood of first degree relatives with dementia of the Alzheimer type were injected into hamsters to test transmissibility in Alzheimer's disease. In animals surviving up to 301 days after inoculation, no evidence of brain disease was present, arguing against transmissibility.